B CELL IMMUNOREGULATION IN CROHN'S DISEASE

Enteric commensal bacterial products elicit immune responses that are key to the tissue-damaging inflammation in humans and animal models with IBD. In the last grant cycle, we collaborated with Project 2 to identify microbial products that reveal a loss of tolerance in CD patients to specific bacterial antigens, and that such patients cluster into groups defined by patterns of serum antibody expression. In particular, patient groups expressing an antibody pattern of the highest amplitude and antigenic diversity (CD-highR) defined a patient subset with uniquely aggressive disease. In mouse models of colitis, the most severe and progressive disease occurs in mice engineered for both high Th1 responses and a lack of regulatory function. Our mouse studies have contributed to the recognition of a "surveillance" subset of B cells that particpate in mucosal immunoregulation and colitis protection through interaction with NKT cells, and CD4+CD8+double-positive (DP) T cells with suppression of Th1 colitis. The hypothesis tested in this next grant cycle is that mucosal surveillance B cells, by their efficient activation of regulatory NKT and DP T cells, promote protection against inflammation and mucosal tissue damage. Accordingly, we predict that impaired formation/function of this B cell subset represents a mode of immunoregulatory failure leading to the aggressive form of human CD observed in the CDhighR patient population. In Aims 1-3, we collaborate with Project 4 in the mouse to develop analytic tools and experimental approaches that model this hypothesis: (1) To define pharmacologic factors that regulate formation of surveillance B cells;(2) To identify the subset of B cells and their mode of interaction with NKT and DP T cells;(3) To test whether attenuated B cell immunoregulation is a susceptibility trait for aggressive colitis. In Aim 4, we collaborate with Projects 1, 2, and Core B to translate our analytic tools to the human, and directly test the hypothesis that the CD-highR subset of human CD patient patients is distinguished by impaired B-cell interaction with immunoregulatory T cell subsets.